Neurometabolomics and Neuroproteomics Center on Cell-Cell Signaling

The UIUC Neuroproteomics and Neurometabolomics Center on Cell-Cell Signaling develops innovative
measurement and analysis tools and provides these tools to the NIDA research community. Rapidly evolving
metabolomics, peptidomics, and proteomics methods facilitate new findings in both discovery and targeted
modes. The Center provides high-end 'omics-scale characterization of the small molecules, peptides, and
proteins in samples obtained from brain sub-regions like defined nuclei and even specific single cells. Our
sampling methods facilitate molecular localization via high-throughput single cell isolation, mass spectrometry
imaging, measurement of activity-dependent release, and quantitation of level changes as a function of exposure
to drugs. We can then characterize the most important molecular targets in these samples using metabolomics,
peptidomics, and proteomics (bottom-up, middle-down, top-down and protein complexes) via a broad array of
mass spectrometry-based technologies. Finally, we provide the critical expertise for capturing the value of data
via expert bioinformatics support that integrates disparate data types, develops advanced analytical approaches
for complex metabolomics and proteomics experiments, and provides community support through several web
platforms. At the beginning of the next project period, we will be supporting an initial group of 12 major users,
representing the fields of addiction research and fundamental neuroscience with projects in cell-cell signaling,
pain, pain management and pain mechanisms (especially as related to opioids), reward and motivation, unusual
neurochemistry, and fundamental questions related to neuronal networks, memory, and behavior. The
Neuroproteomics and Neurometabolomics Center on Cell-Cell Signaling is divided into three research cores: the
Sampling and Separation Core, the Molecular Profiling and Characterization Core, and the Bioinformatics, Data
Analytics and Predictive Modeling Core (plus an Administrative Core), and a Pilot Research Project Core. The
Pilot Core invites new users to interact with our Center and includes an exemplary group of three initial pilot
projects that includes a new investigator and a new research direction for an established investigator. The high
level of synergy between the neuroscientists and technologists affiliated with the Center ensures we will enable
exciting scientific advances in understanding how systems of neurons interact in both the healthy nervous system
and upon exposure to drugs of abuse. Lastly, a series of outreach initiatives assures that our protocols and
approaches are widely available to the appropriate scientific communities.

Public health relevance
Project Narrative Literally hundreds of thousands of chemically distinct molecules are present in every cell in the brain and can be modified based on exposure to drugs of abuse, and yet the technologies to measure and elucidate this chemical complexity are not broadly available. Our Center offers unparalleled measurement capabilities and analytical support to a broad range of drug abuse and fundamental science projects, ensuring their success.